Methods of multi-omics with applications

Since joining NICHD in January 2022, I have hired 1 postdoc and submitted 2 first author papers and am currently submitting a co-author paper.

The first paper has been submitted to Nature Medicine on understanding the connection between autism and the gut microbiome. To explore the functional architecture of autism, we developed an age and sex-matched Bayesian differential ranking algorithm that identified autism-specific profiles across 10 cross-sectional microbiome datasets and 15 other omic datasets, including dietary patterns, metabolomics, cytokine profiles, and human brain expression profiles. The analysis uncovered a highly significant, functional architecture along the GBA that encapsulated the overall heterogeneity of autism phenotypes. This architecture was determined by autism-specific amino acid, carbohydrate and lipid metabolism profiles predominantly encoded by microbial species in the genera Prevotella, Enterococcus, Bifidobacterium, and Desulfovibrio, and was mirrored in brain-associated gene expression profiles and restrictive dietary patterns in individuals with autism. Pro-inflammatory cytokine profiling and virome association analysis further supported the existence of an autism-specific architecture associated with particular microbial genera. Re-analysis of a longitudinal intervention study in autism recapitulated the cross-sectional profiles, and showed a strong association between temporal changes in microbiome composition and autism symptoms. Further elucidation of the functional architecture of autism, including of the role the microbiome plays in it, will require deep, multi-omic longitudinal intervention studies on well-defined stratified cohorts to support causal and mechanistic inference.

The second paper has been submitted to Nature Methods on performing fast protein structure similarity search using novel deep learning approaches. We developed a deep learning method, TM-Vec, that uses sequence alignments to learn structural features that can then be used to search for structure-structure similarities in large sequence databases. We trained TM-Vec to accurately predict TM-scores, a metric of structural similarity for pairs of structures, directly from sequence pairs without the need for intermediate computation or solution of structures.
For remote homologs (sequence similarity <10%) that are highly structurally similar (TM-score > 0.6), we predict TM-align derived TM-scores within 0.026 of their true value.
TM-Vec outperforms traditional sequence alignment methods and performs similar to structure-based alignment methods. TM-Vec was trained on the CATH and SwissModel structural databases and is computationally efficient.It has been tested on carefully curated structure-structure alignment databases that were designed specifically to test very remote homology detection methods. It scales sub-linearly for search against large protein databases and is well suited for discovering remotely homologous proteins.